Communication and Dissemination Core

Project Summary
The overarching goal of the Communication and Dissemination Core (Core C) of the Michigan Center on the
Demography of Aging (MiCDA) is to amplify and measure the impact of research being conducted under the
auspices of MiCDA. Core C will undertake three sets of activities that will engage scholars across disciplines,
career stages and institutions. First, Core C will host a series of conferences, webinars, and symposia. Two
research conferences will be held (in collaboration with Cores B and D), one focused on the changing
demography of late-life disability, dementia and family caregiving and the other on the social, environmental and
biological underpinnings over the life course that shape later-life health and wellbeing. Each conference will
include a cross-cutting focus on the disproportionate distribution of late-life health in the US population and will
result in a special journal issue. We will also host TRENDS lectures that will highlight research on important
health-related demographic trends by an emerging scholar and symposia for MiCDA pilot recipients and early
career MiCDA affiliates. Second, Core C will strengthen communication skills of MiCDA pilot recipients and early
career MiCDA affiliates by offering annual media training, providing opportunities to highlight research findings
via traditional and social media, and facilitating engagement with communications professionals. Third, we will
enhance the visibility of MiCDA’s research through expansions to the MiCDA website–including posting of
materials from conferences, webinars, and network meetings–and a social media plan to promote online
engagement. Core C will also collaborate with Core A on tracking, analyzing and reporting outcomes.